Functional Viromics of Betacoronavirus Entry

PROJECT SUMMARY/ABSTRACT
After the severe acute respiratory coronavirus (SARS-CoV) emerged in China in 2002, the virus was
traced back to animal markets and several genetically related viruses were identified in bats. This early work
into coronavirus zoonosis and the concomitant rise of next generation sequencing technologies in the early
2000’s helped initiate global research efforts to identify viruses circulating in wildlife. The genomes for tens
of thousands of novel animal viruses have now been sequenced and deposited in online repositories.
Coronaviruses are abundant in mammals and birds and comprise approximately 25% of all bat viruses
discovered to date. The highly pathogenic human coronaviruses, SARS-CoV, and middle east respiratory
syndrome coronavirus (MERS-CoV) are only representative members of their respective sarbeco- and
merbeco- subgenera, which encompass hundreds of related viruses found in bats and other wildlife,
worldwide. Unfortunately, because there are few tools available for researchers to study uncharacterized
animal viruses, virus discovery studies rarely isolate viruses under laboratory conditions or perform
experiments beyond genetic sequencing, leaving some of the most essential questions about these viruses –
including if they have the potential to infect humans – unanswered. An improved understanding for what
species these viruses can infect and how they invade the cells of their hosts is essential for future pandemic
preparedness.
The most significant species barrier for the coronaviruses that have transmitted to humans is at the
level of cell entry and studies have shown that overcoming this barrier allows for coronaviruses to replicate in
cells from diverse species. To invade cells, the “spike” glycoprotein on the surface of viral particles binds to
host cell receptor molecules. The receptor binding domain (RBD) is a small region on the distal tip of the
spike protein, capable of folding independently of spike and contains all amino acids that contact the host
receptor. We previously developed “SarbecoType” – a BSL2-compatible, viral pseudotype-based platform to
functionally screen the cell entry properties of the RBD from any sarbecovirus. This approach is highly cost-
efficient and scalable, requiring synthesis of only a small portion of the spike gene, and has allowed us to
characterize the cell entry phenotypes of approximately 95% of all published sarbecoviruses. This dataset
identified multiple clades of sarbecovirus RBDs that vary in their zoonotic properties for humans, and has
formed a foundational basis for ongoing universal sarbecovirus design. Therefore, we hypothesize
uncharacterized coronaviruses pose a threat to humans. Here we propose to functionally screen the much
larger and diverse group of merbecoviruses with similar methods (I.e., “MerbecoType”) and use this entry
data to predict the entry capabilities of novel sarbeco- and merbeco-virus sequences.

Public health relevance
NARRATIVE Coronaviruses such as SARS-CoV-2 originate in animals and transmit to humans. New coronaviruses are discovered and sequenced from wildlife frequently, but, without effective laboratory tools to study these viruses, little is known about the zoonotic risk they pose to humans. We have developed several laboratory-based platforms to characterize the cell entry for hundreds of betacoronaviruses and propose to use these tools to annotate the ever-growing virome.